Innovative Technology for MRI Guided Procedures

The aim of this project is to develop MRI techniques for image-guided minimally invasive diagnostic and therapeutic cardiovascular procedures. Current practice uses X-Ray fluoroscopy for image guidance, whereas MRI provides superior soft tissue visualization, flexible image contrast, and does not expose the patient to ionizing radiation. In the MRI Technology Program, we are focused on two main challenges: imaging speed and imaging safety. In FY2021, we have continued to pursue catheterization procedures using our high-performance 0.55T MRI system configuration. We continue our work to improve visualization of metallic interventional devices. We have explored the susceptibility artifacts generated by various paramagnetic devices across field strengths. In addition, we have improved our visualization of some paramagnetic devices by implementing a novel algorithms to detect the subtle signal that they create. We have developed several cardiac and lung imaging methods for 0.55T, which can be used in combination with invasive catheterization, to examine patients. We continue our collaboration with Dr. Robert Lederman's lab on techniques to visualize ablation lesions and on the development of novel devices for MRI-guided procedures. Moreover, we collaborate closely with industry to make our developments accessible to other institutions.